ERYTHROMYCIN THERAPY IN VENTILATED PREMATURE INFANTS COLONIZED WITH UREAPLASMA

The upper and lower respiratory tracts of preterm infants are frequently colonized with ureaplasma urealyticum. In the intensive care nurseries 20% of infants ventilated for respiratory distress had U. Urealyticum identified on tracheal cultures. The role of this organism in the genesis of chronic lung disease in premature infants has not been resolved.